Views of Gender in Adolescence

Project Summary
Categorization is a fundamental aspect of human cognition that allows for efficient learning, generalization, and
communication. Throughout development, humans categorize the objects, people, and events around them.
The proposed work examines social categorization with a focus on gender. Gender categories are early
emerging, yet influential throughout the lifespan. Broader societal ideas about gender appear to be changing,
however, and this grant asks how those changes may or may not be reflected in how adolescents are
categorizing gender, their beliefs about gender, and their self-categorization by gender. Using a pair of
longitudinal studies, including a 5-year annual study (ongoing from the previous grant period) and a month-long
daily experience sampling study, this grant will document how these constructs are or are not changing
amongst adolescents and the relation between these constructs and their social environments. Finally, in this
work, we examine the links between adolescents’ beliefs about gender, self-categorization with gender, and
their health and well-being. Participants include adolescents and adults who are gender diverse and cisgender.
Together this work will advance theory and practice about topics ranging from categorization and adolescent
gender development to reducing mental health disparities in transgender youth.

Public health relevance
Project Narrative Gender diverse children often experience disparities in mental health and well-being. Further questions concern the stability of their gender as that has implications for medical transitions. The proposed work would examine the role of gender beliefs and self-categorization in predicting mental health and well-being, as well as provide better estimates of rates of stability and change across time in the identities of both cisgender and gender diverse youth.